A Novel Open-Source Optimization Framework for the Design and Simulation of Radiofrequency Coils for Magnetic Resonance Imaging

Project Summary/Abstract
A Novel Open-Source Optimization Framework for the Design and Simulation of Radiofrequency Coils
for Magnetic Resonance Imaging
Radiofrequency (RF) coils are essential in magnetic resonance imaging (MRI) because they affect the obtainable
spatial and temporal resolution, the image homogeneity, and the encoding capability for parallel imaging, among
other things. One limitation of the current approach to coil design is that the quality of a coil can only be compared
against other available coils, giving no indication of whether there is room for further improvement beyond the
best-performing design tested. Theoretical coil performance limits have been proposed as both absolute
references to assess any coil design and target metrics for coil design optimization. The goal of this project is to
develop and demonstrate a novel shape optimization approach for the design of RF coils based on ultimate
performance benchmarks. This project will introduce a new method for rational coil design that relies on rapid
volume-surface integral equation techniques to simulate the coils’ RF fields and advanced shape modeling
algorithms to automatically explore geometric variations and find the optimal design. Starting from a target
anatomical model, a coil substrate tailored to it, and a desired number of channels, our software toolkit will
automatically optimize shape, position and geometric arrangement of the coil elements of an array to minimize
the deviation of the simulated performance from the corresponding theoretical performance limit. This project
will build upon computational electromagnetics methods recently introduced by our group for ultra-fast coil
simulations and the calculation of ideal current patterns associated with optimal performance (ultimate intrinsic
signal-to-noise ratio and ultimate intrinsic transmit efficiency) in realistic anatomical models. We will also rely on
the extensive expertise of the project team with automatic mesh generation and shape optimization with adjoint-
based gradient computation. We will validate the proposed coil design optimization framework in simulations and
experiments. In particular, we will model, simulate, and then construct a flexible receive array for knee imaging
at 3 tesla (T) and a 7 T transmit-receive head and neck coil. We will distribute all software as open source and
fully documented, including tutorials and examples.

Public health relevance
Project Narrative The goal of this project is to develop and demonstrate a novel shape optimization approach for the design of radiofrequency coils based on ultimate performance benchmarks. This project will introduce a new method for rational coil design that relies on rapid volume-surface integral equation techniques to simulate the coils’ radiofrequency fields and advanced shape modeling algorithms to automatically explore geometric variations and find the optimal design. The proposed coil design optimization framework will be validated in simulations and experiments, and released as open-source with potential applications beyond MRI.